Pathology and Biorepository Core (Core B)

SUMMARY: PATHOLOGY AND BIOREPOSITORY CORE (CORE B)
The MD Anderson Brain Cancer SPORE operates in a deeply translational sense, progressing home-grown
experimental treatment strategies to clinical trials to improve patient management. Given the paramount role of
tissue and biomaterial analysis in this process, the Pathology and Biorepository Core has been a key driver of
the success of this grant for many years. In this current proposal, the Core is ideally positioned to continue this
service, having recently incorporated an innovative and near-comprehensive tissue procurement and
processing pipeline. We pair these capabilities with unparalleled histopathological expertise and the wealth of
experience gained over multiple funding cycles and through the support of numerous primary and
developmental projects. For our Specific Aims, we will 1) Procure, bank, and supply relevant tissue and
biomaterial to SPORE projects and the institutional brain tumor research community, 2) Coordinate clinical trial-
associated tissue and biomaterial banking, processing, and databasing, 3) Support murine sample processing
and higher-order human/murine tissue reagent development, 4) Provide histopathological,
immunohistochemical, and molecular pathology expertise, and 5) Facilitate collaboration across the SPORE
network.

Public health relevance
NARRATIVE: PATHOLOGY AND BIOREPOSITORY CORE (CORE B) Research into brain cancer depends on the availability of tumor samples obtained from patients. These samples and the DNA, RNA, proteins, and cells derived from them (e.g. Glioma Stem-like Cell lines) are the foundation of any translational program. This Core provides the patient samples that are key to understanding and curing primary malignant gliomas.